Metabolic pathways in cardiac physiology and heart failure

PROJECT SUMMARY - ABSTRACT
Central to the development of HF are derangements in cardiac metabolism and a shift in fuel utilization. A
recent clinical report of arterial/coronary sinus metabolomics identified glutamine as the most abundant
metabolite released from the failing heart (i.e., production of glutamine rather than catabolism). Glutamine
metabolism is directly linked to bioenergetics, mitochondrial function, redox state, nitrogen balance, and the
biosynthesis of nucleic acids and proteins. Furthermore, we’ve recently shown that glutaminolysis is necessary
for myofibroblast differentiation and persistence, that underlies cardiac fibrosis. Coupled together, these
findings directed us to investigate if cardiomyocyte (CM) glutamine production plays a pivotal role in fibroblast
activation and cardiac fibrosis. In preliminary data generated for the current proposal, we found an appreciable
level of CM glutamine production during stress. Further, we discovered a significant increase in the expression
of glutamine synthetase (GS; glutamate➞glutamine; GLUL gene) and numerous glutamine transporters in
models of HF and in HF patients. These findings support the concept of enhanced CM glutamine production,
and excretion in the stressed heart. To test the role of GS in cardiac pathophysiology, we generated a CM-
specific, tamoxifen-inducible knockout model (GSfl/fl x αMHC-iCre; GS-cKO) and subjected mice to pressure-
overload-induced HF (TAC). Loss of CM glutamine synthesis preserved LV structure and function and
strikingly decreased fibrotic remodeling. In summation, our results suggest paracrine metabolite signaling from
CMs may be a primary mechanism for fibroblast activation in the diseased heart. In addition to changes in
fibroblast activation and ECM deposition, we also noted changes in CM metabolism, including increased
mitochondrial respiratory capacity. In this project we will test the central hypothesis that targeting
cardiomyocyte glutamine synthesis is a multipronged therapeutic strategy to increase bioenergetics, restore
redox balance, and reduce fibroblast activation and fibrosis in HF. 1) We will examine if targeting CM glutamine
synthesis reduces HF development, HFrEF and HFpEF models. 2) Determine if CM-derived glutamine is a
signal/fuel for fibroblast activation, proliferation and myofibroblast differentiation/identity in the stressed heart.
3) Define the impact of targeting glutamine synthetase on cardiomyocyte metabolism, energetics, redox, and
nitrogen balance. All models and methodologies for the proposal have been generated and validated. The
proposed studies will allow for the first-time a causal examination of glutamine synthesis in cardiac physiology
and disease.

Public health relevance
NARRATIVE Heart failure is a pandemic directly impacting ~6.5 million Americans. Central to the development of heart failure are derangements in cardiac metabolism and a shift in fuel utilization. In this project we will test the hypothesis that targeting metabolic pathways in heart cells is a multipronged therapeutic strategy to reduce the burden of heart failure.